The Johns Hopkins University - Uganda Clinical Trials Unit

JHU Uganda CTU Administrative Supplement Request Summary
The JHU Uganda HIV CTU has participated in NIH supported HIV related network treatment and
Prevention trials since the mid 1990’s. The current JHU Uganda CTU organization for this 7 year cycle of
NIH funding is led by three JHU PD/PIS : Dr. Mary Glenn Fowler, administrative PD/PI and Dr. Aaron
Tobian PD/PI based in Baltimore; and Dr. Philippa Musoke, PD/PI based in Uganda. The JHU Uganda
Clinical Research Sites (CRS) are the Baylor Uganda CRS and the Makerere U. Johns Hopkins U. (MUJHU)
CRS, located on the Mulago National Hospital complex in Kampala Uganda. The current networks that
the two CRSs participate in include the ACTG, IMPAACT, and HPTN. The MUJHU CRS is also completing
MTN 042 trial addressing PrEP during pregnancy and has participated in a number of other MTN trials.
The AIMS of the JHU Uganda CTU are to carry out HIV prevention and treatment trials; behavioral
studies addressing improving adherence to PrEP and HIV treatment; vaccine and immunotherapy trials;
TB prophylaxis and treatment trials; vaccines and immunotherapy trials for emerging infections; and
mentoring the next generation of independent HIV researchers in Uganda. The investigators at the CTU
and CRSs actively contribute to Scientific Committees of the HIV networks and support the Network
research agendas.
The purpose of this JHU Uganda CTU/CRS Yr 18 administrative supplement request is to further
strengthen the MUJHU and Baylor Uganda CRS infrastructure in conducting the network HIV prevention
and treatment trials, and to provide further technical support and training of researchers and clinical
staff at the two Uganda CRSs. The supplement request includes support for both CRSs in terms of
strengthening IT, administrative infrastructure; refurbishing of pharmacy and clinical facilities, and
purchase of updated equipment and supplies necessary for conduct of the DAIDS network trials. In
addition the administrative supplement request will also support travel to the network meetings from
two Uganda CRSs; as well as travel funds for one JHU staff to make one additional site visit to the CRSs
in 3rd quarter; and for one additional JHU staff member to attend the September IMPAACT meeting in
Washington DC.

Public health relevance
JHU Uganda CTU Administrative Supplement Narrative Yr 18 The purpose of this administrative supplement request for UM AI-069530 is to request much needed infrastructure funding to support the JHU Uganda CTU and its two CRSs in Kampala Uganda: The Baylor Uganda and the MUJHU CRS. These requested funds for the two CRSs will support staff training, much needed equipment and supplies; as well as internet capability and pharmacy and clinic facility infrastructure. The requested travel funds for the JHU Uganda CTU will allow for one extra international trip by JHU CTU staff to provide on the ground technical assistance focused on completion of remote monitoring training and launching of new protocols over the next 7 months, as well to allow participation of one additional JHU staff member in the HIV network meetings being held in June, and September 2024.